BRL49653C COMBINATION WITH GLYBURIDE TO PATIENTS WITH DIABETES

This study will provide safety data to support the use of BRL 49653C in combination with glyburide in the management of patients with NIDDM.